NHLBI ENTERPRISE RISK MANAGEMENT (ERM) PROGRAM - EXERCISING OPTION PERIOD 2 FOR TASK A

The NHLBI Enterprise Risk Management Program (ERM) supports risk identification, assessment, evaluation, and reporting across the breadth of NHLBI's diverse operational and scientific portfolios.